Nurses Health Study 3: A multiple exposure environmental epidemiology cohort of young adults

PROJECT SUMMARY
This is an R24 application to support the infrastructure of our environmental epidemiology cohort, Nurses’
Health Study 3 (NHS3), an open, prospective, web-based cohort (www.nhs3.org). Participants are residence
of the United States and Canada born after 1965. Most of the female participants (89%) have enrolled before
menopause and 41% of female participants and 62% of male participants have no prior pregnancy history. In
this innovative web-based study, we have been collecting detailed information on personal characteristics and
potential disease risk factors every 6 months, including diet, physical activity, psychosocial factors, and a wide
variety of occupational and environmental exposures. Data collection has focused on current exposures, as
well as those experienced during adolescence, prior to first pregnancy, and during pregnancy. Discoveries
made in NHS3 will build on the knowledge and experience gained from earlier cohorts on the impacts of the
environment on chronic disease risk, but takes advantage of modern technology to collect novel prospective
data during important windows of exposure across the life course. The NHS3 investigators have substantial
experience in environmental epidemiology, exposure assessment, and Big Data analytics, as well as in
managing and maintaining large prospective cohort studies. This cohort provides a unique opportunity to
address key outstanding questions in environmental epidemiology, by collecting highly detailed information on
multiple environmental exposures at key points in the life course.
Here, we propose to support infrastructure activities in the expanded NHS3 cohort that maximize the existing
resources and broaden the current scope of research, to allow the investigation of multiple environmental
exposures. We will focus our efforts in three main areas: 1) the expansion of study operations and
maximization of existing resources, 2) the collection of environmental exposure samples, and 3) expansion of
web-based mobile technologies and assessment of spatial uncertainty and measurement error.

Public health relevance
PROJECT NARRATIVE In the innovative web-based Nurses’ Health Study 3 Cohort, we have been collecting detailed information on personal characteristics and potential disease risk factors every 6 months, including diet, physical activity, psychosocial factors, and a wide variety of environmental exposures. Data collection has focused on current exposures, as well as those experienced during adolescence, prior to first pregnancy, and before, during and immediately after pregnancy. Enhancing the breadth and depth of environmental exposure assessment in this cohort study will allow us to address key outstanding questions in environmental epidemiology in the future.